Mississippi INBRE

MISSISSIPPI INBRE
OVERALL
Project Summary/Abstract
The Mississippi IDeA Network of Biomedical Research Excellence (MS INBRE) is a statewide network
dedicated to enhancing biomedical research at all institutions of higher education in Mississippi. The overall
goal of the network is to build the biomedical research workforce needed to address health disparities and
inequities in MS by improving leadership and capabilities. With this goal in mind, the MS INBRE has developed
its activities around three scientific themes that disproportionally impact Mississippians: cancer, infectious
diseases, and obesity. MS is ranked second lowest in the United States in terms of access to healthcare,
primarily owing to the state's small economy and historically low investment in health care infrastructure. This
is mirrored in MS's biomedical research infrastructure, which has lagged in comparison to other states. The
result is a vicious cycle in which it is more difficult to make improvements in health care equality and
availability. This makes investments, embodied by the MS INBRE program, key to improving the biomedical
infrastructure at partner institutions that will provide the education and training to underserved communities
who have historically suffered from severe health disparities. The following aims have been developed to
accomplish the overall goal of the MS INBRE: 1) Improve research capacity at Primarily Undergraduate
Institutes (PUIs) in Mississippi; 2) Build collaboration among academic scientists and community-based
organizations; and 3) Develop a skilled and diverse workforce in biomedical research and health-related
careers. At the completion of the proposed project, we will augment the competitiveness of Mississippi in
biomedical research by improving biomedical research infrastructure, enabling research at undergraduate
institutions and training of students that address the needs of Mississippians.

Public health relevance
Project Narrative: The Mississippi INBRE is designed to improve biomedical research in the state and positively impact student training. This will be accomplished by 1) supporting the research enterprise at primarily undergraduate institutes, 2) Promoting collaboration among biomedical researchers, and 3) by training students in biomedical research and increasing diversity in the health-related career workforce.